Impact of excitatory synapse maturation on synaptic plasticity and stability

Immature excitatory synapses in the perinatal brain contain high release probability (Pr) presynaptic terminals
coupled to postsynaptic specializations with GluN2B subunit-containing NMDA receptors (hi-Pr, hi-GluN2B
synapses). For over two decades, we have known that these immature synapses mature in an activity-
dependent manner to low-Pr, low-GluN2B synapses, but the mechanisms that coordinate this transition, why it
occurs, and how it contributes to circuit plasticity and stability remain controversial and are fundamental
unanswered questions. Addressing these issues will identify basic mechanisms that control synapse
development and that may be disrupted in neurodevelopmental and psychiatric disorders. Disruption of the
Arg/Abl2 kinase in mice yields a population of hi-Pr, hi-GluN2B synapses that persist into early adulthood. The
persistence of these immature synapses drives a >40% net loss of hippocampal synapses between postnatal
day (P) 21 and P42, and impairs synaptic plasticity and behavior. Building on these findings, we will identify
new regulators of synapse maturation, and determine how they regulate synaptic plasticity and stability.
In Aim 1, we will identify the cell surface receptors that activate Arg to coordinate the maturation from hi-Pr, hi-
GluN2B synapses to low-Pr, low-GluN2B synapses. We provide preliminary data that integrin α3β1 adhesion
receptor and platelet-derived growth factor receptor β (PDGFRβ) act upstream of Arg to control synapse
function and stability. We will use selective gene inactivation in the pre- and postsynaptic neurons along with
genetic epistasis and rescue experiments to address how and where these receptors interact with Arg and
each other to regulate Pr and postsynaptic GluN2B levels.
In Aim 2, we will elucidate how Arg mediates GluN2B downregulation at the synapse. Arg-mediated signaling
is critical to downregulate GluN2B during maturation. We identified the SHP2 tyrosine phosphatase and the
NMDAR-associated protein BRAG1, both mutated in intellectual disability, as likely functional links between
Arg and developmental GluN2B downregulation. We will use biochemical, cell-based, and genetic approaches
to test how Arg interacts with SHP2 and BRAG1 to downregulate GluN2B function.
In Aim 3, we will characterize how immature and mature synapses differentially contribute to plasticity and
stability. We will use patterned glutamate uncaging at single synapses to test whether hi-Pr, hi-GluN2B and
low-Pr, low-GluN2B synapses have altered ability to undergo long-term potentiation (LTP) and long-term
depression (LTD) in arg–/– mice. We will use in vivo imaging to examine how enlarged dendritic spines at hi-
Pr, hi-GluN2B cortical synapses in arg–/– mice differ from normal spines in their plasticity and stability.
Our studies will elucidate the mechanisms by which receptors act through Arg and its downstream targets to
control Pr and NMDAR composition during synapse maturation. Disruption of these mechanisms may underlie
the defects in synapse development, plasticity, and stability in intellectual disability and other brain disorders.

Public health relevance
The connections between nerve cells, called synapses, do not form or function properly in the brains of individuals with autism and intellectual disability, and become destabilized in psychiatric diseases and neurodegenerative diseases. We have discovered a signaling network that controls synapse maturation and have shown that disruption of this network in mice causes significant synapse loss and defects in learning, memory, and other behaviors. We will determine how this signaling network regulates synapse maturation to preserve the proper function of nerve circuits and their ability to support learning and memory.